Play & Learning Across a Year (PLAY)

PROJECT SUMMARY
The overall goal of the PLAY (Play & Learning Across a Year) project is to catalyze discovery about
behavioral development in infancy. PLAY will focus on the critical period from 12 to 24 months of age when
infants show remarkable advances in language, object interaction, locomotion, and emotion regulation. PLAY
will leverage the joint expertise of 63 “launch group” researchers, and capitalize on the Databrary video-sharing
library and Datavyu video-coding tool to exploit the power of video to reveal the richness and complexity of
behavior. Together, PLAY researchers will collect, transcribe, code, share, and use a video corpus of infant
and mother naturalistic activity in the home to test behavioral, developmental, and environmental cascades.
The project will demonstrate the value and feasibility of a cross-domain synergistic approach, and advance
new ways to use video as documentation to facilitate discovery and ensure transparency and reproducibility.
Aim 1 is to create the first, cross-domain, large-scale, transcribed, coded, and curated video corpus of
human behavior—collected with a common protocol and coded with common criteria jointly developed by the
launch group. The corpus will consist of videos of 900 infant-mother dyads (300 12-, 18-, and 24-month-olds)
from 30 diverse sites across the United States. Videos will be transcribed and coded for infant and mother
communicative acts, gestures, object interactions, locomotion, and emotion. The corpus will be augmented
with video home tours and questionnaire data on infant language, temperament, locomotion/fall injuries,
gender identity and socialization; home environment and media use; and family health and demographics.
Aim 2 is to leverage the potential of time-locked video codes to test critical questions about behavioral,
developmental, and environmental cascades—from one domain to another, between infants and mothers, and
from the macro environment (e.g., SES, geographic region, home language) and proximal home environment
(e.g., objects for play, home chaos and clutter) to infant and mother behaviors.
Aim 3 is to advance new ways to use video as documentation to ensure scientific transparency and
reproducibility. The entire protocol and code definitions are documented in a wiki with exemplar video clips to
illustrate text-based descriptions. The entire corpus and all tools will be openly shared with the developmental
and behavioral science communities on Databrary and in other language and behavior repositories (CHILDES,
HomeBank, WordBank, OSF).
PLAY will create a cross-domain, shared video corpus of unprecedented scope and richness. It will
provide launch group members and the larger research community with the data, tools, and know-how to use
time-locked video codes to investigate the unfolding of natural behavior in real time. The novel, synergistic
approach to crowdsourcing the research will reduce overall costs while increasing scientific payoffs. The use of
shared video as both data and documentation will accelerate the pace of discovery in developmental science.

Public health relevance
PROJECT NARRATIVE To ensure the clinical significance of the PLAY project, the launch group includes 14 researchers with expertise in atypical development and 9 researchers with expertise in poverty and environmental risk, who all helped to design the sampling method, protocol, and video codes; confirmed the work has translational relevance; and ensured the protocol and codes can be extended to atypical and at-risk populations. Questionnaires will include parent-report health indicators, and family history of communicative disorders and mental illness; video home tours will yield objective data about home environment risks; SES and Census Block Group codes will inform on family and community-level risks.